Lipoprotein trafficking to the bacterial outer membrane

ABSTRACT
Gram-negative bacteria produce an outer membrane (OM) that envelopes the cell. The OM is an essential
organelle and a potent permeability barrier that blocks the entry of many antibiotics, limiting clinical options. The
OM is at a distance from the cytosol, separated from the inner membrane (IM) by a periplasmic space. Yet, all
OM components are synthesized in the cytosol. The orchestrated actions of dedicated molecular machines and
chaperones ensure efficient transport and assembly of each component into the OM bilayer. Lipoproteins (lipid-
anchored proteins) are key to building the OM. Almost all essential OM assembly machines require at least one
OM lipoprotein for function. After being secreted from the cytosol, nascent lipoproteins are modified with three
acyl chains, anchoring them into the IM. The cell must subsequently extract, and traffic these highly hydrophobic
lipoproteins through an unfavorable aqueous periplasmic environment to the OM for insertion into the bilayer.
The Escherichia coli “Lol pathway” was the paradigm for how lipoproteins are trafficked: the periplasmic protein
LolA triggers release of lipoproteins from the IM and chaperones them to the OM where LolB inserts them. We
discovered that, while LolA and LolB are important for trafficking, the genes encoding both proteins can be
deleted and yet efficient lipoprotein trafficking continues in their absence. Our finding reveals that additional
factors can traffic essential OM lipoproteins to sustain viability. We aim to uncover the factors responsible for
LolAB-independent lipoprotein trafficking and understand why multiple routes exist. We now know that the Cpx
two-component system continuously monitors OM lipoprotein trafficking in E. coli. If defects arise, Cpx acts to
restore homeostasis and preserve viability. We aim to define the key toxicities that occur and how these are
mitigated by Cpx. We will expand our understanding of stress and homeostasis by investigating how distantly
related bacteria that lack Cpx monitor and mitigate trafficking stress, identifying new cell envelope stress
responses. Since we can now make LolAB conditionally non-essential, we are uniquely placed to thoroughly
dissect the molecular mechanisms of lipoprotein trafficking. We will utilize deep mutational scanning alongside
complementary biochemical studies to directly capture lipoprotein trafficking intermediates to shed light on their
mechanisms. The E. coli paradigm falls short in many diverse Gram-negative species, and we have limited
understanding of their OM assembly. We discovered that many LolB-lacking species produce a bifunctional LolA
chaperone that also fulfils insertase function (delegated to LolB in E. coli). How such proteins achieve
unidirectional trafficking to the OM is not known and we will dissect the proteins and processes involved. Our
research program will move our understanding of trafficking beyond the E. coli model and into diverse pathogens
(Acinetobacter baumannii and Campylobacter jejuni). Gram-negative species are now a major cause of deaths
attributable to antibiotic resistance. The crucial roles that lipoproteins play in building the OM makes their
trafficking a focus of ongoing novel antibiotic development. Our discoveries will further empower those efforts.

Public health relevance
PROJECT NARRATIVE The outer membrane (OM) of Gram-negative bacteria is an essential organelle and a key antibiotic resistance determinant. The trafficking of lipid-anchored lipoproteins to the OM is a critical process for these bacteria since the molecular machines that build the OM each require at least one essential lipoprotein to function. We have uncovered the existence of novel lipoprotein trafficking routes and aim to develop a comprehensive understanding of lipoprotein trafficking and OM homeostasis that will empower efforts to therapeutically target the OM with new antibiotics.